Administrative Core

ADMINISTRATIVE CORE
ABSTRACT
The Administrative Core of this U19 Center will be responsible for coordinating all activities associated
with the CW2IP2. This will include the scheduling of the biweekly calls of the Center Executive Steering
Committee and other Center participants. The Administrative Core will also organize the annual meeting
of the External Liaison Committee and participate in the monthly meetings of the NINDS Proteinopathy
Imaging Consortium. The Administrative Core will provide the oversight needed to direct the efficient
operation of the CW2IP2 on a day-to-day basis, such as the shipment of research materials between the
different labs involved in the consortium, financial oversight of the U19 Center, and be responsible for
obtaining regulatory approval for the PET radiotracers chosen for translation for first-in-human studies.
The core will be directed by Robert H. Mach, Ph.D. the Director of this U19 Center application.
Given the collaborative interactions between the different groups of the Medicinal Chemistry and
Radiochemistry (MCRC) Core, and the interactions between the MCRC Core and Projects 1 and 2, we
found that the bi-weekly calls are essential in maintaining communication between the basic science
research labs of this U19 Center. Since the competing renewal of this U19 Center will feature a very
active translational imaging component, the Clinical Core will also provide an update on patient
recruitment and progress achieved at the different clinical imaging sites.